Pilot Project Program

Pilot Project Program (PPP) ABSTRACT
The Pilot Project Program (PPP) of the Texas A&M Center for Environmental Health Research (TiCER) is to
stimulate research on the mechanisms underlying environmental health risks, to facilitate formation of
interdisciplinary teams to address important environmental health challenges, to encourage research into
environmental concerns of affected communities, and to develop science-based mitigation strategies to real-
world problems and communicate these findings to various stakeholders, including policy makers. The PPP will
serve a critical role within the Center by funding outstanding, innovative, and early-stage environmental health
research projects. These projects will address one or more of the four thematic areas of the Center and serve to
attract new faculty into environmental health research. This will be achieved by: (1) Developing a well-structured
pilot project program to enhance environmental health research; (2) Recruiting and supporting junior
investigators into environmental health research; (3) Expanding faculty participation and creation of
interdisciplinary teams; and (4) Encouraging collaborations beyond Texas A&M.